Advancing Student Potential for Inclusion with Research Experiences (ASPIRE)

The Advancing Student Potential for Inclusion with Research Experiences (ASPIRE) Program at the Medical College of Wisconsin (MCW) seeks to increase the biomedical workforce with cardiovascular research experiences through a 10-week summer program for undergraduates. ASPIRE will fill a great need at MCW for federally-supported undergraduate training in cardiovascular research as MCW historically receives 500 to 700 more applications each spring from undergraduates than available summer positions. We will provide apprentice-style mentoring for our trainees from our 36 accomplished faculty mentors embedded within the MCW Cardiovascular Research Center’s thematic areas of research expertise (“Signature Programs”), which are: 1) atherosclerosis, thrombosis, and vascular biology, 2) cardiac biology and heart failure, 3) cardio-oncology, and 4) hypertension. Our program is designed to enhance “science identity” and disciplinary knowledge and skills to support belonging, attitude, competence, knowledge, and skills by engaging trainees in experiential research, personalized learning opportunities about science, technology, engineering, mathematics, and medicine (STEMM) careers (MD Track, PhD Track, or General Science Career Track), and avenues for further training (i.e., graduate school, professional school), in addition to providing professional skills for career advancement and tools for breaking down barriers, thriving, and resilience. We will draw on our extensive background with the national recruitment and mentoring of trainees, leverage existing MCW resources, and provide innovative professional skills and “survival skills” seminars and experiences in a welcoming, well-resourced environment. With strong institutional support and excellence in cardiovascular research (ranked #13 of medical schools in funding from NHLBI recently), we will leverage our experienced multi-PI leadership, oversight by an informed Advisory Committee, and well-resourced experienced faculty mentors to meet our intermediate and long-term benchmarks of success: to enroll and train 13 sophomore, junior, or senior-level undergraduate trainees each summer (65 trainees over the 5-year period of the award), provide tailored, relevant, and cutting-edge training in research and professional skills, expose trainees to the multitudinous career opportunities in STEMM, enable trainees to present their research at a MCW research symposium at the end of the 10 weeks of training (and if possible, at a national research conference the following year), and for 80% or more of our ASPIRE graduates to complete their undergraduate degree in a STEMM field, more than 50% to apply to graduate school or other biomedical-related advanced degree programs, and 75% to obtain a first job in STEMM. Overall, the ultimate goal of the ASPIRE Program is to inspire and fully-equip our undergraduate trainees for future careers within STEMM, especially in areas related to cardiovascular research, thereby enhancing the strength of the future biomedical workforce.

Public health relevance
This is a request for a new R25 award to support summer experiences at the Medical College of Wisconsin (MCW) in Milwaukee for undergraduate students to receive hands-on cardiovascular research experiences, training in science-related skills, education about careers available in science, technology, engineering, mathematics, and medicine (STEMM), and learn tools for breaking down barriers, thriving, and resilience that are tailored to the trainee’s intended career path of becoming a physician, a scientist, or working in another STEMM-related career. MCW receives 500 to 700 more applications each spring semester from undergraduates than available summer positions so there is great need at MCW for federal support of this R25, and the MCW Cardiovascular Research Center has 36 well-trained, well-funded faculty mentors available within its four areas of research expertise in which to provide this training: 1) atherosclerosis, thrombosis, and vascular biology (plaque, blood clots, and blood vessel health), 2) cardiac biology and heart failure (heart structure and function), 3) cardio-oncology (cancer’s effects on heart and blood vessel health), and 4) hypertension (high blood pressure). At a time when the burden of cardiovascular disease continues to rise and strengthening of the biomedical workforce is greatly needed, our training program is designed to inspire and fully-equip our undergraduate trainees for future careers within STEMM, especially in areas related to cardiovascular research, thereby enhancing the future biomedical workforce.